Is immune system TSH-beta splice variant a causative factor in autoimmune thyroiditis?

PROJECT SUMMARY/ABSTRACT Autoimmune thyroiditis (AIT) affects several million people in the U.S., and many more worldwide. Although much of the pathophysiology of AIT is understood, and various treatment protocols are available, the events that trigger the autoimmune process remain sketchy. Knowledge of that is essential in order to fully understand how AIT is initiate and perpetuate. It has been known for over three decades that thyroid stimulating hormone (TSH) is produced by cells of the immune system; however, the significance of that remains elusive. Our laboratory identified a novel splice variant of the β-subunit of TSH (TSHβv), the first alternatively spliced form of TSHβ to be identified in mice and humans. Of particular interest, TSHβv is the only form of TSHβ produced by the immune system. We have speculated that under normal physiological conditions immune system-derived TSHβv may play a role in maintaining the homeostatic balance in thyroid hormone output and host metabolic activity, but that the continual presence of TSHβv-producing leukocytes in the thyroid may be a causative factor in the development of thyroiditis. Support for this comes from findings from our laboratory in which splenic leukocytes traffic to the thyroid and secrete TSHβv during bacterial and viral infection, from preliminary studies showing increased intrathyroidal TSHβv expression in a murine model of AIT, and from studies by others demonstrating an increase in TSHβv expression in patients with Hashimoto’s thyroiditis, a form of AIT. The hypothesis to be tested is that intrathyroidal production of immune system TSHβv is a causative factor in the pathogenesis of AIT, and that suppression of immune system TSHβv in mice will prevent or significantly ameliorate AIT. This will be done using an established animal model of AIT (NOD.H2h4 mice) through two specific aims. Aim 1: To identify the source of immune system TSHβv in mice with AIT. Aim 2: To knockdown TSHβv in vivo in cells of the immune system to assess its involvement in AIT. If TSHβv is found to be a factor in driving AIT, it will provide new perspectives from which to mechanistically understand the inflammatory process in AIT in ways that have not been realized to the present. A better understanding of that could have significant heuristic benefits for developing novel patient treatment protocols.

Public health relevance
PROJECT NARRATIVE Autoimmune thyroiditis (AIT) is a chronic inflammatory condition that affects several million people in the U.S., and considerably more worldwide. Although many aspects of the pathophysiologic response in AIT are understood, almost nothing is known about the events that initiate the disease. We identified a novel splice variant of the thyroid stimulating hormone β-subunit that is produced by cells of the immune system. Using an animal model of human AIT, we will selectively disrupt the production of TSHβv within the immune system to test the hypothesis that TSHβv is a contributing factor in the development of AIT. Findings from these studies could have significant implications for elucidating the underlying cause(s) of AIT, and could significantly influence the way in which thyroiditis is treated.